The Center for Innovation in Point-of-Care Technologies for HIV/AIDS at Northwestern University (C-THAN)

“The Point-of-Care Technologies for HIV Viral Load Program” (POC-HVL) is an administrative
supplement to the Center for Innovation in Point-of-Care Technologies for HIV/AIDS at Northwestern University
(C-THAN) Cooperative Agreement (U54 EB027049). POC-HVL will expand its current development pipeline of
products for HIV/AIDS and its many morbidities and will develop a pipeline of needs-based, point-of-care
technologies critical for improving the management of persons living with HIV/AIDS by specifically focusing on
technologies that can measure plasma HIV RNA (viral load) at point-of-care. POC-HVL will harness the C-
THAN expertise, research experience and clinical networks in the United States and Africa.
The United Nations Program on HIV and AIDS (UNAIDS) has set the ambitious 95-95-95 goal to
achieve detection of 95% of HIV cases, treatment for 95% of those cases, and viral suppression for 95% of
those treated by 2025 and ending the HIV/AIDS pandemic by 2030. Significant progress has been made in
controlling the HIV epidemic in the past 20 years, however, success in many areas has lagged and many
countries have not reached the UNAIDS targets. In 2019, approximately 1.7 million people worldwide became
infected with HIV, and 690,000 died from HIV-related illnesses. There has been substantial improvement in
diagnosing infected patients and a significant improvement in overall generic drug pricing. The estimate cost
of a one year course of TDF/3TC/DTG combination therapy is now $59. The total cost for that medical therapy
in all 164 countries with treatment programs would be $2 billion annually; while global expenditure on HIV
pharmaceuticals is $28 billion, this is now a feasible prospect. Lacking however, are broadly available tests
that can measure treatment efficacy. The current standard is molecular-based, mostly performed in central
labs, and relatively expensive. There is a need for accurate, rapid, and less expensive viral load testing at the
point-of-care. Until this gap is filled, UNAIDS targets are unlikely to be achieved. C-THAN will serve as a
platform for the support of products to develop POC technologies that address this unmet need to effectively
monitor and document success of the current HIV treatment programs. Such a product can also serve as an
effective diagnostic tool capable of diagnosing very early infection and infection in children <18 months of age.
The C-THAN structure will incorporate clinical and user needs in project development while providing
expertise and resources to address early barriers to commercialization and implementation. Its Core
components will operate in an integrated manner to deliver a scope of work, entailing: 1) collaboration with
relevant scientists, physicians, researchers, and engineers; 2) development of essential technical, clinical,
industrial, and regulatory partnerships, and 3) testing of prototype POC devices in the field. The POC-HVL
program will have a major impact on the management of persons treated with antiretroviral therapies and will
assist in the UNAIDS goal of eliminating HIV infection worldwide.

Public health relevance
Narrative The Point-of-Care Technologies for HIV Viral Load Program (POC-HVL) is a critical component of the Center for Point-of-Care Technologies for HIV/AIDS at Northwestern University (C-THAN), itself a part of the NIBIB Point-of-Care Technologies Research Network (POCTRN). The mission of POC-HVL is to develop needs- based, point-of-care technologies that specifically measure plasma HIV RNA (viral load) at the point-of-care. Utilizing the existing C-THAN structure, this program will incorporate clinical and user needs in project development while providing expertise and resources to address early barriers to commercialization and implementation.